Role of Ca2+ in B. anthracis exosporium assembly

PROJECT SUMMARY
Bacillus anthracis is a Gram-positive soil bacterium that forms spores when starved for nutrients, and
contact with these spores causes anthrax in animals and humans. B. anthracis spores are surrounded by
three protective layers, the outermost of which is a loosely fitting exosporium. The exosporium plays key roles
in spore survival and infectivity. Over the past two decades, there has been significant progress in identifying
the proteins that comprise the exosporium and their functions, however, the assembly process is poorly
understood. This proposal explores a previously unrecognized role for Ca2+ in exosporium assembly.
The exosporium is a bipartite structure consisting of a paracrystalline basal layer and an external hair-
like nap. Each filament of the nap is formed by a trimer of the collagen-like glycoprotein BclA. In contrast, the
basal layer contains ~25 different proteins. One of these proteins is called BxpB, which appears to play two
critical roles in exosporium assembly. First, BxpB trimers form an array of basal layer surface protrusions to
which individual BclA-containing filaments are stably attached. Second, BxpB binds to and stabilizes the
structure of an underlying basal layer scaffold formed by protein self-assembly. In the absence of BxpB, the
scaffold is structurally disordered and the insertion of other basal layer proteins is aberrant.
We recently published the crystal structure of the BxpB trimer. Each monomer folds into a jelly roll
structure composed of two antiparallel b-sheets. An unexpected feature of the BxpB monomer was a bound
Ca2+ ion hexa-coordinated by oxygen atoms of four residues located on neighboring loops that connect the two
b-sheets. The bound Ca2+ appears to stabilize the relative positions of the two b-sheets thereby fixing a major
element of BxpB structure. In addition, recent structural studies of the BclA-BxpB complex reveal that the
BxpB-bound Ca2+ establishes the structure of a peripheral region of BxpB that closely interacts with BclA.
Presumably, the activities of BxpB in exosporium assembly require the Ca2+-dependent structures.
The goal of this R03 proposal is to investigate the role for Ca2+ in BxpB structure and function. Aim 1 is
to produce Ca2+-free BxpB, determine its structure by X-ray crystallography (or NMR), and compare this
structure to that of Ca2+-bound BxpB. Aim 2 is to assess the ability of Ca2+-free BxpB to form stable complexes
with BclA and to normally insert into the basal layer scaffold. The expected outcome is the demonstration of a
critical role for Ca2+ in BxpB structure and exosporium assembly in B. anthracis spores. This situation is likely
to apply to many spore-forming bacterial species, including important pathogens, that possess a BxpB
homolog and produce an exosporium that is structurally like that of B. anthracis. The discoveries in this
proposal will significantly enhance our understanding of bacterial spore formation and potentially lead to better
responses to the adverse effects of disease-causing spores.

Public health relevance
PROJECT NARRATIVE This proposal is relevant to public health because it elucidates a fundamental and general property of bacterial spore formation that plays a critical role in causing human disease. These studies are relevant to NIH’s mission to acquire knowledge that is important in the development of new strategies to treat and prevent infections disease. These studies are also important for NIH's national defense mission because they define a critical feature of Bacillus anthracis spores, the causative agent of anthrax and a serious threat as an agent of bioterrorism.